RNA Modifications in Health and Disease

ABSTRACT
Support is requested for a Keystone Symposia conference entitled RNA Modifications in Health and Disease,
organized by Drs. Eric Miska, Ramesh S. Pillai and Eva Maria Novoa Pardo. The conference will be held in
Banff, Canada from December 12-15, 2023.
Chemical modifications of RNA nucleotides, collectively referred to as the epitranscriptome, represent an
additional layer of information encoded in transcribed RNA sequences. By analogy to epigenetic mechanisms,
RNA modifications are reversibly added by ‘writer’ and ‘eraser’ enzymes and these ‘marks’ are interpreted by
‘reader’ proteins. Characterization of the structural diversity of RNA modifications and elucidation of their roles
in biological pathways represent central motivations of this emerging field, which has been supported by new
technology development and mechanistic analysis by scientists interested in RNA biology. Basic discoveries in
epitranscriptomics are being translated toward the clinic at an accelerating rate. Our understanding of the
function and regulation of RNA modifications, as well as their roles in human infection, immunity and disease is
deepening in parallel with the advancement of RNA-based medicines, such as mRNA-based COVID-19 vaccines
or antisense oligonucleotides (ASOs). This conference will bring together leading experts focused on RNA
modifications, technology development and medicine to discuss cutting edge research, evaluate data standards
in the field and identify opportunities for the translational potential of targeting RNA modification pathways. We
anticipate that participants of this conference will benefit by sharing results on this rapidly advancing topic, but
also in defining the future direction of the field and creating new collaborations to accelerate progress.

Public health relevance
PROJECT NARRATIVE 'Epitranscriptomics’ focuses on defining the structures and biological functions of chemical modifications of cellular RNAs. By profiling these ‘marks’ in transcriptome-wide approaches and characterizing the proteins that install and interpret them, researchers are unveiling new biology and potential targets for therapeutic intervention. This Keystone Symposia conference will provide a forum for researchers from around the world to discuss cutting-edge discoveries related to RNA modifications, define new directions for the field and identify avenues for developing new medicines for a variety of diseases including viral infections and cancer.